The Role of Nutrition in the Development/Progression of Alcohol-Induced Organ Injury

The University of Louisville Alcohol Research Center (ULARC) was created to serve as a
regional/national resource to perform interdisciplinary collaborative research on the role of nutrition as
a cofactor in alcohol induced organ injury and as a possible therapeutic intervention to prevent/treat
this organ injury. The nutrition and alcohol-induced organ injury theme of the center is unique among
alcohol centers. The approach is highly translational. Our investigators include faculty from 13 departments
and 6 colleges. The Specific Aims of the ULARC are to:
1) perform/facilitate interdisciplinary research on nutrition and alcohol-induced organ injury;
2) serve as a regional/national resource for the study of nutrition and alcohol-induced organ injury;
3) develop potential therapeutic targets/interventions for alcohol induced organ injury based on the
mechanistic research of the ULARC; and
4) disseminate knowledge/interventions to the scientific and lay communities.
We will explore interactions of nutrition and alcohol abuse in the development of alcohol-induced organ
dysfunction, and we will evaluate diverse potential nutritional preventive/therapeutic interventions. Project 1
(Kirpich/McClain) evaluates the role of dietary fat in ALD pathogenesis; Project 2 (Barve) evaluates alcohol-
induced epigenetic alterations in the gut:liver axis. Project 3 (Chen) will elucidate the mechanisms by which
enhancers mediate ethanol-induced developmental impairment of neural crest cells and teratogenesis and
unique exosome treatment for prevention of FASD. Project 4 (Feng) studies the beneficial effects of the
probiotic, Lactobacillus rhamnosis GG (LGG)on the gut:liver axis in ALD.
Together, these projects form a cohesive and interactive approach to investigate the effects of nutrition and
nutritional interventions on alcohol-induced organ injury.

Public health relevance
Alcohol abuse exacts a major toll on health and health costs in the United States and is the 3rd leading preventable cause of death in the U.S. There is no FDA-approved therapy for most forms of alcohol- induced organ injury such as alcoholic liver disease. Our focus on nutrition and alcohol-induced organ injury should lead to new therapeutic targets, new nutritional preventions/treatments, and improved mortality and morbidity.